Biological Aging, the Proteome and Cognitive Resilience among Ischemic Stroke Survivors

Project Summary/Abstract
To date, there is no effective treatment for cognitive impairment and dementia. Understanding mechanisms
that promote cognitive resilience and delay vascular dementia, particularly in high-risk populations, is a
complimentary approach to extend cognitive health span. Ischemic stroke survivors represent a growing
population among older adults in the U.S. and a very high-risk group for Alzheimer’s disease and related
dementias (ADRD). Beyond the underlying burden of brain infarction, biological factors and molecular
mechanisms that elicit differences in cognitive resilience and timing of dementia onset after stroke, remain
unclear. Biological aging processes at the physiological level are associated with risk of age-related diseases
including cognition, stroke and dementia. However, it remains poorly understood if differences in biological
aging explain variabilities in post-stroke ADRD. At the molecular level, among recognized aging biology
mechanisms, the proteome plays a central role as proteins control cell functions, can help identify novel
therapeutic targets and are associated with cognitive trajectories in aging. However, these associations were
restricted to post-mortem assessments and have not been assessed in accessible tissue such as peripheral
blood and in vulnerable populations such as ischemic stroke survivors. The immediate objective of this
application is to assess the role of biological aging and molecular proteomic mechanisms in cognitive resilience
and timing of onset of vascular dementia among ischemic stroke survivors. I will measure biological aging
using physiological biomarkers data collected from blood tests in the Cardiovascular Health Study (CHS) and
the Rotterdam Study (RS). I will then integrate these phenotypes with state-of-the art clinical ascertainment of
stroke and cognition over >15 years of follow-up to assess the role of biological aging differences in cognitive
resilience after stroke. I will leverage an Aptamer-based proteomic platform to identify molecular networks and
cellular-level pathways of biological aging, cognitive resilience and vascular dementia among stroke survivors
and healthy controls. I will evaluate algorithms of combined biological aging, proteomic and clinical stroke data
for prognosis of cognitive resilience and domain-specific cognitive outcomes using supervised machine
learning. I am well suited to perform this research based on 1) my prior research experience in epidemiology of
stroke and aging, 2) the outstanding mentoring team to ensure this research is of highest quality; and 3) the
exceptional research environment to support my career development. The proposed training and research will
help me acquire substantive new skills in molecular epidemiology, high-dimensional data and machine learning
to establish an independent career as a researcher at the intersection of molecular epidemiology and ADRD in
vulnerable populations. This project will enable unprecedented perspectives on biological and molecular
mechanisms of cognitive resilience to uncover novel biomarkers and therapeutic targets to protect cognitive
health in old age among ischemic stroke survivors.

Public health relevance
Project Narrative Ischemic stroke survivors represent a growing population among older adults in the U.S. and a very high-risk group for Alzheimer’s disease and related dementias (ADRD), however factors and mechanisms that contribute to preserving cognitive health and timing of dementia onset in this population remain unclear. We will examine the role of biological aging in cognitive resilience and timing of dementia onset after stroke and molecular pathways underlying this relationship through integration of state-of-the art clinical assessments of stroke and cognition over more than 15 years of follow-up with algorithmic combinations of physiological biomarkers and molecular proteomic data in diverse samples from well- established cohorts. This research will help identify novel biomarkers and molecular proteomic pathways of cognitive resilience to open up new avenues for protection of cognitive health and primary prevention of vascular dementia among ischemic stroke survivors and beyond.